Mechanisms of Sex-specific Metabolic Disruption Caused by Organophosphate Flame Retardant Exposure

Project Abstract: Tris(1,3-dichloro-2-propyl) phosphate (TDCPP) is an organophosphate flame retardant used
to meet federal and state flammability standards of various consumer products. Off-gassing causes TDCPP to
accumulate in dust and contaminate indoor spaces. TDCPP is stable in the environment, but when it enters the
body, which is most commonly via hand-to-mouth contact, TDCPP is readily metabolized to bis(1,3-dichloro-2-
propyl) phosphate (BDCPP). Ninety percent of Americans have detectable BDCPP in their urine, indicating
ubiquitous exposure. Studies utilizing data from the National Health and Nutrition Examination Survey found a
significant positive association between urinary BDCPP levels and metabolic syndrome, with the components
central adiposity and hyperglycemia carrying the association. Interestingly, the association with BDCPP and
metabolic syndrome was found only in men. We have developed a mouse model of TDCPP exposure that
reproduces male sex-specific metabolic disruption. TDCPP is incorporated into purified low phytoestrogen diets
to mimic the primary route of exposure in humans. When fed this diet, male wild-type mice have increased
percent body fat and insulin resistance. Euglycemic clamp showed insulin resistance was liver-specific. We
screened TDCPP in vitro for agonist activity against 26 nuclear receptors and found that TDCPP activates only
farnesoid X and pregnane X receptors (PXR). However, in livers of TDCPP-treated mice, only PXR target genes
were differentially expressed. Building upon our preliminary findings, our proposed studies will test the overall
hypothesis that PXR activation mediates male sex-specific TDCPP-induced hepatic insulin resistance. To
increase clinical translation of the proposed research, we will use transgenic mice expressing the human PXR
(hPXR) gene. Our preliminary studies show transgenic hPXR mice are at least 100x more sensitive to TDCPP-
induced metabolic disruption than wild-type mice. We will interrogate insulin action and signaling in livers of male
and female hPXR mice. Using PXR deficient mice and dietary exposure to BDCPP, which is not a PXR agonist,
we will determine whether PXR activation is necessary to confer metabolic disruption. We will gonadectomize
male and female mice to determine whether TDCPP-induced metabolic disruption is sex hormone-dependent.
Finally, to further elucidate the mechanistic underpinnings of TDCPP's sex-specific metabolic disruption, we will
perform mRNA sequencing of livers from hPXR, PXR deficient, and castrated male and female mice exposed to
TDCPP. The proposed preclinical studies fill a critical emergent knowledge gap regarding whether the ubiquitous
environmental contaminant, TDCPP, promotes development of metabolic syndrome. Successful completion of
the proposed studies will drive future knowledge toward interventions and screening strategies to identify
metabolically innocuous flame retardants; and furthermore, progress our understanding of xenobiotic-mediated
sex differences, which may be generalizable to many other endocrine disrupting chemicals.

Public health relevance
Project Narrative: Over 90% of Americans are exposed to the flame-retardant chemical tris(1,3-dichloro-2- propyl) phosphate (TDCPP). TDCPP exposure is positively associated with metabolic syndrome in men, but women are protected from its harmful effects. The proposed studies interrogate the role of nuclear receptors and sex hormones in conferring sex-specific metabolic disruption associated with TDCPP exposure, which will drive our knowledge toward interventions and screening strategies for less harmful flame retardants.